TNF-alpha-"armed" TCR vectors to enhance adoptive cell therapy for solid tumors

PROJECT SUMMARY/ABSTRACT
Cancer immunotherapy with T-cells expressing a transgenic T-cell receptor (TCR) or chimeric antigen receptor
(CAR) can generate dramatic clinical responses in a variety of solid tumors. However, a significant number of
patients do not respond to therapy. We have previously shown that increased secretion activity of tumor necrosis
factor alpha (TNF-alpha) is associated with superior clinical responses to TCR-T cell therapy. Furthermore, we
have shown that increased TNF-alpha activity reduces immunosuppressive T helper 2 (Th2) cell activity, which
is associated with inferior response to therapy due to their anti-effector functionality. We have generated novel
lentiviral vectors which simultaneously encode for TNF-alpha along with a tumor antigen-specific TCR or CAR
(which we have termed a TNF-alpha-“armed” TCR/CAR vector). Treatment with TNF-alpha-armed TCR-T cells
results in enhanced anti-tumor activity in vitro and in vivo in preliminary humanized mouse xenograft studies.
Importantly, the improved antitumor functionality was not associated with increased systemic toxicity, due to the
antigen-dependent nature of the increased TNF-alpha secretion.
We hypothesize that utilizing TNF-alpha-armed TCR/CAR-T cells will result in superior antitumor efficacy
of the transgenic T-cells compared to conventional TCR/CAR-T cells. We will explore our hypothesis in a
wide variety of TCRs and CARs and associated tumor types via two related but independent aims.
Aim 1 will evaluate the impact of transgenic TNF-alpha co-delivery with a transgenic TCR or CAR on T-cell anti-
tumor functionality and toxicology in humanized murine xenografts, as well as T-cell infiltration into the tumor
microenvironment and gene expression patterns of the tumor tissue in response to the increased TNF-alpha
activity via spatial transcriptomics/proteomics. We hypothesize that TNF-alpha-armed TCR/CARs will result in
superior anti-tumor functionality in vivo compared to conventional TCR/CAR-T cells without increased toxicity.
Aim 2 will explore the T-cell intrinsic impact of increased TNF-alpha activity on T-cell functional phenotype and
the underlying signaling mechanisms in the face of chronic antigen stimulation. Tumor-infiltrating lymphocytes
obtained from the same humanized mouse xenografts obtained in Aim 1 will be interrogated with mass cytometry,
single-cell cytokinetic polyfunctionality assays, and single-cell phospho-proteomics. Repetitive tumor cell
stimulation assays in vitro, as well as TNF-receptor-2 knockouts will serve as confirmatory experiments. We
hypothesize that the addition of transgenic TNF-alpha to TCR/CAR-T cell therapeutics will augment TNF-
alpha/TNF-receptor 2 signaling, leading to inhibition of Th2 immunosuppressive cytokinetic activity.
This project represents an innovative approach to improve transgenic T-cell therapeutics and further elucidate
the role of TNF-alpha in T-cell biology. Our findings will set the stage for the translation of TNF-alpha-armed
TCR/CAR T-cells into the next generation of adoptive T-cell therapies for solid tumors.

Public health relevance
PROJECT NARRATIVE Cellular immunotherapies such as transgenic T-cell receptor (TCR) and chimeric antigen receptor (CAR) T-cells are revolutionizing the treatment of multiple cancer types, but there remain significant incidences of treatment failure or relapsed disease after an initial clinical response. We have shown that increased T-cell secretion of tumor necrosis factor alpha (TNF-alpha) is associated with superior clinical responses to TCR T-cell therapies for solid tumors, and have generated a novel lentiviral vector which simultaneously encodes for TNF-alpha along with a tumor antigen TCR or CAR. This project will test the hypothesis that using this vector to enhance TCR-T and CAR-T cells’ capacity for antigen-dependent TNF-alpha secretion improves the cells’ anti-tumor functionality, as well as the transgenic T-cell phenotypic functionality over time.